Striatum Wide Dynamics and Neuromodulation of Cell-Type Specific Striatum Populations during Learning

PROJECT SUMMARY/ABSTRACT
The striatum, the principle input nucleus of the basal ganglia, is a central mediator of associative learning for
evaluating, motivating, and directing appropriate actions in response to external stimuli. Behavioral studies
have suggested that distinct sub-regions of the striatum make unique contributions to adaptive learning, and
that dysfunction in particular corticostriatal circuits may explain the range of learning and motivational deficits
observed in basal ganglia disorders such as Parkinson’s Disease and addiction. Learning related changes in
striatum neurons are widely believed to be driven by dopamine dependent bi-directional synaptic plasticity in
distinct populations of direct and indirect pathway output neurons. This proposal will investigate how large
scale, cell-type specific neural dynamics across distinct sub-networks of the striatum evolve to evaluate
external cues, select appropriate actions, and invigorate movement over the course of sensori-motor learning.
We will use a new optical approach we have developed to monitor and manipulate signals from two distinct
output pathways of the striatum across a large 3-dimensional volume in head-fixed behaving mice during types
of learning known to depend on different striatal sub-circuits. We will investigate the causal contribution of
distributed dopaminergic signaling to bi-directional learning related changes in striatum output neurons by
measuring and manipulating patterns of region specific dopamine release across the striatum volume during
learning. Finally, we will employ 2-photon calcium imaging to track activity in hundreds of individual striatum
neurons across days and determine how large scale learning related changes in striatum ensembles result
from day to day changes at the single cell and network levels. Results from the proposed studies will provide
new insight into how spatiotemporal changes in cell-type specific striatum output mediate central aspects of
adaptive learning and action selection, and ultimately, how neurological disorders of learning and motivation
might result from regional dysfunctions in distinct striatum networks.

Public health relevance
PROJECT NARRATIVE Distinct anatomical subregions of the striatum are known to make unique contributions to different aspects of sensor-motor learning, and region-specific striatum dysfunction has been attributed to a range of symptoms in neurological disorders. How cell-type specific striatum dynamics evolve during learning to support adaptive learning is poorly understood. This proposal will advance new optical approaches to determine how distinct output signals evolve across the entire striatum during learning and how they are shaped by ongoing neuromodulatory input, providing fundamental insight into circuit level mechanisms of normal behavior and potential targeted therapeutics for disease.